The role of cell interactions in shaping development

PROJECT SUMMARY
Interactions between cells direct many aspects of embryonic development. The long-term goal of our research
program is to learn how cell interactions determine the shape, organization, and function of developing cells,
tissues, and organs. Using C. elegans as an in vivo model where genetic analysis, live imaging and cell biology
can be combined, we have developed several simple experimental systems to investigate how cell interactions
regulate conserved morphogenetic events. The specific goals of this proposal are to use these model systems
to fill key gaps in understanding how cells develop polarity, how small tubes form, and how niche cell
interactions regulate germ cell biology.
In one project, we are investigating how cell contact induces apicobasal polarity. This project addresses
two outstanding questions – how cell contacts induce the PAR protein asymmetries that polarize cells, and
how PAR proteins elaborate other intracellular asymmetries. We previously discovered that E-cadherin signals
to induce polarity by recruiting the RhoGAP PAC-1, which triggers PAR protein asymmetries. We will extend
these findings by uncovering new molecular links connecting PAC-1 to the E-cadherin cytoplasmic tail, by
identifying additional signaling pathways that contribute to polarization, and by investigating how the PAR
protein aPKC induces the formation of epithelial junctions.
In a second project, we are investigating how small tubes develop. Small tubes such as capillaries can
form in the cytoplasm of a cell when vesicles are targeted to an invading apical domain. It is unclear how
vesicles are targeted to this site to form intracellular tubes. We are addressing this question by determining
how the excretory cell forms an intracellular tube. We found that PAR proteins localize the exocyst vesicle-
tethering complex to direct vesicle fusion events to the invading apical domain, and will extend these findings
by investigating how PAR proteins recruit the exocyst and how the initial site for tube formation is specified.
In a final project, we are determining how niche cell interactions influence germ cell development. Niche
cells wrap membrane extensions around germ cells and stem cells but the significance of these interactions is
poorly understood. We discovered that primordial germ cells (PGCs) extend large protrusions that are wrapped
and cannibalized by intestinal cells, eliminating most PGC mitochondria. We will determine the importance of
PGC lobe cannibalism, testing the hypothesis that it helps ensure the health of germline mitochondria.
Together, our findings will reveal new, basic insights into how cell interactions guide critical developmental
events, providing a foundation for understanding the contribution of cell interactions in human development
and disease.

Public health relevance
PROJECT NARRATIVE Physical interactions between cells influence many important aspects of embryo development. This proposal uses the nematode embryo as a model system to determine how cellular interactions regulate the shape, organization, and function of cells, tissues, and organs. Our findings will provide insights into how cell interactions contribute to human embryo development, and how defective cellular interactions can contribute to birth defects and diseases such as cancer.